Remodeling of the electron transport chain in macrophages by a novel peptide-miRNA axis

Project Summary/Abstract:
Macrophages are critical innate immune cells which are necessary for anti-pathogen immunity, cancer
immunosurveillance and wound healing. Powering these diverse responses in macrophages is the dynamically
regulated electron transport chain (ETC) within the mitochondria. An important regulator of ETC function is
complex IV (CIV), which is critical for oxygen consumption, ATP generation, and cell survival. Humans with loss-
of-function mutations in CIV subunits present with severe immunodeficiencies characterized by recurrent
bacterial and viral infection, highlighting the importance of CIV in immune responses. Intriguingly, CIV is the only
respiratory complex which remodels its protein subunit composition in response to environmental stimuli, such
as hypoxia, to modulate its function. This is achieved through the upregulation of subunit isoforms which replace
highly homologous core CIV subunits that function to improve cellular fitness. However, whether immune cells
remodel CIV subunit composition during immune responses and whether this remodeling is important for myeloid
cell function is unknown. Since inflammatory responses are powerful external stimuli that result in mitochondrial
reprogramming, I hypothesized that CIV subunit composition is remodeled in macrophages and functions
to regulate inflammatory responses. To this end, I identified a single transcript (AA467197) induced in pro-
inflammatory macrophages which encodes a miRNA (miR-147) and a highly conserved peptide (NMES1) with
striking homology to the CIV subunit NDUFA4. Intriguingly, my preliminary data and recent studies indicate that
NMES1 and miR-147 work in concert to replace the core CIV subunit NDUFA4 with NMES1 in CIV. Strikingly,
while remodeling of CIV subunit composition by NMES1 and miR-147 was dispensable for ATP production, I
showed that this subunit switch played a critical role in regulating inflammatory cell death induced by NLRP3
inflammasome activation, termed pyroptosis. While mitochondrial function is modulated in macrophages during
priming by pro-inflammatory signals such as LPS, it also can be critical in enhancing activation of the NLRP3
inflammasome through the production of ROS, release of mtDNA, externalization of cardiolipin, and regulation
of ion flux in the mitochondria. Thus, our overall hypothesis is that NMES1 and miR-147 remodel CIV subunit
composition in macrophages to increase NLRP3 inflammasome activation in vitro and in vivo. To explore
this hypothesis, I will use macrophages sufficient or deficient in AA467197 to uncover how remodeling of CIV by
NMES1 and miR-147 impacts CIV function to induce pyroptotic cell death. Additionally, I will conditionally delete
AA467197 in relevant cell types and employ bacterial infection models to pinpoint how NMES1 and miR-147
regulate NLRP3 inflammasome activation and anti-bacterial immunity in vivo. Altogether, this proposal will
elucidate the cellular and molecular mechanisms that underlie the impact of CIV remodeling in macrophages on
shaping innate immune responses to bacterial infection.

Public health relevance
Project Narrative An important mitochondrial control point in immune cells is complex IV (CIV) of the electron transport chain (ETC), which fuels innate immune responses to pathogens. CIV is the only mitochondrial respiratory complex that modulates its function by remodeling its protein subunit composition, however, whether CIV protein subunit composition is remodeled in immune cells during inflammatory responses or if this contributes to innate immune responses is unknown. The experiments outlined in this proposal will unambiguously determine the mechanisms by which CIV subunit composition is remodeled in macrophages to regulate NLRP3 inflammasome activation and anti-bacterial immunity.